Exposure-Response Relationships for Low Back Pain from Pooled Data

? DESCRIPTION (provided by applicant): The proposed research offers a unique opportunity to quantify exposure-response relationships between measured occupational biomechanical stressors and prevalence and incidence of three low back pain (LBP) outcomes while adjusting for demographics, LBP history, and psychosocial factors. The three LBP outcomes are: (i) LBP, (ii) Seeking Care for LBP (SC-LBP), and (iii) LBP resulting in lost time (LT-LBP). This study will pool previously collected, raw data from three independently conducted prospective cohort studies. Combined, these studies enrolled workers from 47 US workplaces, representing a wide range of occupations, industries, and physical exposure levels. A total of 1,855 employees were enrolled and 1,275 were followed for up to 54 months (1,903 person-years of follow-up data). Compatible, comprehensive data are available on each worker (i.e., exposure to biomechanical stressors, relevant covariates, and LBP outcomes). Measures of biomechanical stressors used in this study include the: (i) Lifting Index (LI), and (ii) Composite Lifting Index (CLI) from the Revised NIOSH Lifting Equation, and (iii) a newly proposed Cumulative Lifting Index (CULI) that accounts for job rotation and quantifies integrated biomechanical stressors to a worker over an entire work-shift using an innovative, incremental approach. Our comprehensive physical exposure data feature: (i) quantified physical exposure to individual workers measured at baseline, (ii) quantified changes in exposures over time, and (iii) detailed data for each combination of weight lifted/lowered, repetition, horizontal and vertical locations of hands, trave distance, type of grasp and trunk posture (i.e., sub-task data). These pooled data will have more robust distributions and statistical power to: (i) estimate exposure-response relationships between biomechanical stressors (LI, CLI, CULI) and LBP outcomes (LBP, SC-LBP and LT-LBP), (ii) recommend safe exposure limits, and (iii) identify important covariates. Pooling existing data from these three studies will enable us to estimate magnitudes and shapes of relative risks as continuous functions across a wide range of biomechanical stressors: (i) with improved confidence and precision, (ii) for workers with job rotation, and (iii) for tasks with varied combinations of physical exposure risk factors, such as: weight lifted//lowered, repetition, and horizontal and vertical locations of hands. Results from this proposed research will help employers to design safe and productive jobs and provide public-health agencies and occupational health and safety professionals with information to more effectively guide workplace injury prevention programs. Among others, this study addresses the NORA Manufacturing, Services, and Warehousing Sectors and the Exposure Assessments, Musculoskeletal and Authoritative Recommendations Cross-Sectors.

Public health relevance
PUBLIC HEALTH RELEVANCE: The objectives of this study are to determine: (i) risk factors for low back pain (LBP) and (ii) quantitative relationships between job physical demands and three LBP outcomes (LBP, seeking care for LBP, and LBP resulting in time away from work). Findings from this study will be useful to employers, employees, and health and safety practitioners to design and modify workplaces to reduce workplace LBP, which is frequent cause of activity limitation and lost workdays. This study will create a large dataset by merging previously collected, relevant physical exposure, demographic, psychosocial, and LBP outcome information on 1,855 workers from three prospective epidemiological studies. Analyses of this pooled raw data will provide important new information about the risk of the above three LBP outcomes attributable to specific manual lifting and lowering tasks assessed using the most commonly used job analysis method (Revised NIOSH Lifting Equation). These analyses will account for confounding and/or effect modification from worker demographics, past LBP history, and psychosocial factors, and with better precision and statistical power than any previous analyses.